The Neuroinflammatory Impact of Binge Ethanol Exposure in Aged Mice: A Role for NLRP3.

PROJECT SUMMARY
Forty percent of aged adults (>65 years of age) consume alcohol and the population of aged adults that
participate in binge drinking is growing. Despite a concurrent increase in the number of age-related
neurodegenerative diseases like Alzheimer's disease and related dementias, the effect binge drinking has on
the aged brain and neurodegeneration is not well understood. Although dysregulated host immunity and
heightened production of pro-inflammatory mediators are significant and independent contributors to both age-
and alcohol-related neurodegeneration, the combined effect of alcohol and advanced age on neuroinflammation
is not well characterized. Our preliminary data demonstrate that following binge ethanol exposure, the production
of pro-inflammatory cytokines in the hippocampus is greater in aged mice compared to young. The goal of this
proposal is to identify specific mechanisms leading to heightened neuroinflammatory responses to ethanol in the
aged brain. Activation of both the NLRP3 inflammasome and microglia, the resident macrophages of the central
nervous system, are critical factors leading to alcohol-induced neuroinflammation and injury in the young brain.
Moreover, aging models have established NLRP3 and heightened microglia activation as central factors leading
to amplified inflammatory responses and associated neuronal damage in the aged brain. The specific
contribution of NLRP3 in driving enhanced neuroinflammatory responses to ethanol, including microglia
activation, in advanced age has not yet been defined. It is our working hypothesis that relative to young,
binge ethanol exposure leads to heightened activation of microglia, excessive neuroinflammation and
associated neurodegeneration in the aged brain. Moreover, we hypothesize that these exaggerated
responses to ethanol in advanced age are NLRP3 dependent. To test this, in Aim 1 we will comprehensively
characterize the effect of binge ethanol exposure on neuroinflammation, neurodegeneration, and cognitive
impairment in young and aged mice using multispectral imaging and behavioral assays. We will then define the
role of NLRP3 as an important contributor for advanced age- and ethanol-related hippocampal damage by
making use of NLRP3 knockout young and aged mice. In Aim 2, we will elucidate the cell-specific role of NLRP3
in primary microglia harvested from young and aged mice. We will characterize microglia phenotype after ex vivo
ethanol exposure of primary microglia and take the novel approach to use the specific NLRP3 inhibitor, OLT1177,
to alleviate ethanol-induced inflammation in primary microglia from the young and aged brain. Together, these
studies will unveil how alcohol-misuse during aging may contribute to neurodegenerative disease pathogenesis
and identify new therapeutic targets to prevent age- and alcohol-related neurodegeneration.

Public health relevance
PROJECT NARRATIVE In the United States, the population of aged adults (>65 years of age) is expected to reach 90 million people by 2050, and 40% of aged adults people consume alcohol. Alcohol misuse is associated with dementia in older adults; however, the mechanisms remain unclear. The proposed studies will focus on defining the impact and cellular mechanisms associated with enhanced neuroinflammatory response to ethanol in aged brain which may lead to novel treatment targets to prevent neurodegenerative disease.